Expert curation of clinically significant variants in genes for early onset retinal degeneration

PROJECT SUMMARY/ABSTRACT
The goal of this proposal is to curate clinically relevant variants in genes associated with the inherited
monogenic diseases autosomal recessive Leber congenital amaurosis (LCA) and early-onset Retinal
Dystrophy (eoRD) that cause lifelong blindness beginning in infancy or childhood. More than 30 genes
associated with these phenotypes have been identified and the first gene replacement therapy was approved
for LCA/eoRD associated with RPE65 variants. Clinical and pre-clinical trials are currently underway to treat
disease caused by other genes. A major limitation in the path to treatment is the lack of uniform classification
criteria optimized on a gene-by-gene basis that would enable accurate and consistent interpretation of the
clinical relevance of variants found in patients seeking treatment. In a previously funded project we
assembled a variant curation expert panel (VCEP) within ClinGen – the NIH-sponsored Clinical Genome
Resource – to identify the most clinically important LCA/eoRD genes and to curate the most clinically
actionable variants in those genes. Variants curated within the ClinGen structure and deposited into ClinVar
constitute an FDA-designated expert-level resource for interpretation of genetic test results and facilitate
delivery of personalized patient care. This LCA/eoRD VCEP is comprised of an international group of experts
with in-depth knowledge in LCA/eoRD genetics and clinical care, with wide-ranging expertise in variant
classification. In combination with ClinGen leadership, the VCEP has begun to curate variants in genes
associated with LCA/eoRD phenotypes for which gene therapies are available, or clinical or advanced pre-
clinical studies are underway. The ClinGen protocol for establishing VCEP curation activities has been
completed for the RPE65 gene and will soon be completed for the GUCY2D gene. The proposed project
continues this work and involves two Specific Aims: 1. Completion of gene-specific rules for AIPL1 and
CEP290, which were started under the previous project, and development of specifications for additional
LCA/eoRD genes including LCA5, RDH12, and CRB1, and 2. Sustained curation of variants in each gene as
it is approved by ClinGen, with attention to building collaborations that will lead to improved curation methods.
All steps will be carried out with the approval of the ClinGen Clinical Domain Working Group Oversight
Committee utilizing a suite of variant curation tools and protocols developed by ClinGen. The proposed
project will lead to the development of variant interpretation criteria that are in harmony with rules established
for other diseases and optimized for LCA/eoRD genes, and generate FDA-designated expert level variant
classifications in the ClinVar public database. This information will advance research on LCA/eoRD and
enable accurate, consistent, high-quality interpretation of genetic test results, and improve patient care.
Further, the rules specified by the LCA/eoRD VCEP will advance development of rules for other IRDs and
other hereditary diseases.

Public health relevance
PROJECT NARRATIVE The goal of our proposal is to define the clinical relevance of genetic variants associated with Leber congenital amaurosis (LCA) and early onset retinal degeneration (eoRD) by continuing the work of our variant curation expert panel (VCEP) to develop disease-gene specified rules for curation, and to systematically classify variants, implementing the specified rules and ClinGen-approved protocols. The results will generate an FDA expert level approved resource of accurately classified variants in LCA/eoRD genes that will improve the consistency and accuracy of interpreting diagnostic genetic test results, leading to more precise diagnosis and improved medical care.